Recurrence and Resistance in the Aging Melanoma Microenvironment

Metastatic recurrence in melanoma patients often occurs when dormant tumor cells at distant
sites reawaken, even after seemingly successful initial treatment. This process of tumor
dormancy, where disseminated tumor cells remain inactive before eventual reactivation, remains
poorly understood despite its clinical significance. Notably, aging emerges as a critical factor in
poor melanoma prognosis, suggesting that age-related changes in the tissue environment may
influence both tumor dormancy and therapeutic resistance. Our research has revealed that aged
lung fibroblasts significantly impact how melanoma cells emerge from dormancy through complex
Wnt signaling pathways. Recent findings demonstrate a crucial switch between non-canonical
and canonical Wnt signaling that appears to control entry into and exit from tumor dormancy.
Additionally, we have discovered that host factors, including sex, influence age-related metastatic
spread and treatment response.
Particularly intriguing is our observation that aged fibroblasts, unlike their younger counterparts,
show unique responses to the presence of cancer cells, even at distant sites. These aged
fibroblasts increase their proliferation and secrete factors that create an immunosuppressive
environment by recruiting myeloid-derived suppressor cells. This immune-suppressed
environment may then permit the growth of rapidly proliferating cells that would typically be
eliminated by immune surveillance.
The relationship between dormancy and therapy resistance presents another critical aspect of
this research. While Wnt5A drives resistance to targeted therapy through a senescence-like state,
canonical Wnt signaling typically increases sensitivity to BRAF/MEK inhibitors. Understanding
how these opposing pathways interact, particularly in the context of aging, may reveal new
therapeutic opportunities. This research aims to uncover how the aging immune
microenvironment influences tumor cell dormancy and subsequent recurrence. By investigating
the complex interplay between stromal cells, immune components, and Wnt signaling pathways,
we hope to identify new therapeutic strategies to prevent metastatic recurrence in aging
melanoma patients. These findings could lead to more effective treatments that consider both the
age of the patient and the dynamic nature of tumor dormancy.

Public health relevance
Melanoma patients often face cancer recurrence when dormant tumor cells “wake up” and start growing again at distant sites in the body, a process that becomes more likely as patients age. Our research has discovered that aging changes how normal tissue cells interact with these dormant cancer cells, particularly through specific cellular signals that can suppress the immune system's ability to fight cancer. By understanding exactly how aging affects this process, we aim to develop new treatments that could prevent cancer recurrence in older melanoma patients, potentially by helping their immune system better control dormant cancer cells.